AI Mount Sinai: High-performance computational and data ecosystem for biomedical discovery

Abstract:
Affordable and available modern computational and data resources for AI-driven
biomedical research projects are in short supply. AI Mount Sinai (AIMS) addresses this
gap by providing state-of-the-art GPU capability and capacity for 42 research projects at
26 institutions. Research areas include: (1) AI for medical imaging and multi-modal
clinical data, (2) structural and chemical biology, and (3) genetics and genomic sciences.
Resulting research products will be disseminated through publications and national data
repositories, including but not limited to: dbGAP, TOPMed, AMP-AD, CommonMind,
PsychENCODE, BRAIN, Autism Sequencing Consortium and GEO, with the overarching
goal of catalyzing translational science.
AIMS consists of six Lenovo ThinkSystem SR780a V3 servers for a total of 48 NVIDIA
B200 GPUs connected via NVLink and Infiniband NDR400. There are 9 terabytes of
memory available on the Graphics Processing Units (GPUs), and an additional 12
terabytes available on the server nodes. Local high-speed NVME storage and DDR5 RAM
enables caching of intermediate results by 672 compute cores on the compute nodes.
Other features include a job scheduler, parallel file system and archival storage system.
Mount Sinai is supplying networking infrastructure, short- and long-term storage and
other essential supplies. Five years of operating costs, including expert personnel,
facilities (power, cooling and space), hardware and software maintenance is also being
funded by Mount Sinai to meet the acute scientific need for AIMS. Expert PhD and MD
computational and data scientists' collaborate with biomedical researchers through
extensive training and researcher engagement activities to maximize researcher
productivity.
The broad, long-term objectives of AIMS focus on improving our collective
understanding of human disease in the following areas: Alzheimer's, autism,
schizophrenia and related behavioral disorders, cardiovascular disease, kidney disease,
diabetes type 2, drug addiction, depression and cancer. Without AIMS, there would be
slower progress towards the diagnosis and treatment of these conditions affecting
human health.

Public health relevance
Narrative: AI Mount Sinai (AIMS) is a high-performance computational and data ecosystem designed to improve the diagnosis, prognosis and treatment of the following diseases: Alzheimer's, autism, schizophrenia and related behavioral disorders, cardiovascular disease, kidney disease, diabetes type 2, drug addiction, depression and cancer. AIMS accelerates biomedical research with modern computational and data science resources that are otherwise unavailable. Biomedical research projects will share their data and discoveries through publications and national data repositories.